Pin1-Catalyzed Protein Conformational Regulation in Alzheimer's Disease

DESCRIPTION (provided by applicant): The neuropathological hallmarks of Alzheimer's disease (AD) are tangles made of hyperphosphorylated tau (p- tau) and plaques consisted of Abeta deposits. Tau hyperphosphorylation especially on Ser or Thr residues before Pro (pSer/Thr-Pro) precedes tangle formation. We have recently found that certain pSer/Thr-Pro motifs exist in two distinct cis and trans conformations and identified a unique enzyme, Pin1 that specifically catalyzes their isomerization in vitro. Importantly, Pin1 controls a subset of key regulators to help coordinate their functions and its deregulation can contribute to certain diseases, notably AD. Pin1 acts on the pThr231-Pro motif in p-tau to inhibit tau-related pathology (tauopathy) and on the pThr668-Pro motif in APP to reduce A?- pathology. Pin1 knockout mice develop age-dependent tau- and A?-pathologies, whereas Pin1 overexpression inhibits tauopathy in mice. These results are relevant to human AD because Pin1 is inhibited in MCI and AD neurons by various mechanisms, but preventing Pin1 inhibition is associated with delayed onset of AD. Human Pin1 gene is located to 19p13.2, a new locus associated with late-onset AD. We thus proposed that Pin1 might help protect against neurodegeneration in AD by regulating protein conformations. However, a major challenge is the lack of any tool available that is able to distinguish cis from trans pSer/Thr-Pro conformation in a native protein. Thus there is no direct evidence for the presence of these two p- tau conformations and their conformation-specific functions or regulation in tauopathy. Moreover, whether Pin1 and p-tau conformations play any role in cognitive function relevant to AD is also not known. To address these critical issues, we developed Pin1 conditional knockout mice and a novel technology to generate a first pair of antibodies able to detect specifically cis or trans pThr231-Pro motif in p-tau. Our preliminary results suggest that Pin1 increased cis to trans isomerization of pThr231-tau in vitro and in mice, and that cis, but not trans, pThr231-tau was significantly elevated in MCI brains, and further accumulated in AD. This proposal is designed to test our hypotheses that the pathological p-tau is conformation-specific and that modulating such conformation by Pin1 and others would affect tauopathy and cognitive function relevant to AD. Aim 1 is to determine which p-tau conformations are pathologicaly more relevant during tauopathy using AD mouse models and human AD samples. Aim 2 is to determine the impact of modulating p-tau conformations by Pin1 and other methods on tauopathy in mice, and the relationship between Pin1 and tau conformations in human AD, and the mechanisms underlying the Pin1 action in vitro and in cells. Aim 3 is to use neuron-specific Pin1 knockout or overexpression or other methods to determine the role of Pin1 and p-tau conformations in cognitive function relevant to AD. These experiments would further define the role of Pin1 and its catalyzed conformational changes in AD, and could lead to new strategies for treating tauopathy. These studies would offer the first in vivo approach to study post-phosphorylation conformational regulation. PUBLIC HEALTH RELEVANCE: The incidence of Alzheimer<s disease likely increases rapidly as people live longer, but currently the pathogenic mechanisms are still not fully understood and there is no effective therapy. Recently, we have identified a unique enzyme called Pin1 that may be important for helping keep Alzheimer<s disease at bay. The goal of this proposal is to further understand how Pin1 performs this important function at the molecular level and to determine whether Pin1 is important for protecting against memory loss in Alzheimer<s disease. These studies would lead to a better understanding of Alzheimer<s pathogenesis and could potentially lead to the development of new strategies for early diagnosis and/or treatment of this devastating disease.

Public health relevance
The incidence of Alzheimer<s disease likely increases rapidly as people live longer, but currently the pathogenic mechanisms are still not fully understood and there is no effective therapy. Recently, we have identified a unique enzyme called Pin1 that may be important for helping keep Alzheimer<s disease at bay. The goal of this proposal is to further understand how Pin1 performs this important function at the molecular level and to determine whether Pin1 is important for protecting against memory loss in Alzheimer<s disease. These studies would lead to a better understanding of Alzheimer<s pathogenesis and could potentially lead to the development of new strategies for early diagnosis and/or treatment of this devastating disease.